Unified group sequential designs for clustered data (eye level) in randomized eye trials

ABSTRACT
Interim data monitoring is essential to the successful design, conduct, and reporting of long-term
randomized clinical trials for eye diseases. Group sequential methods are the most commonly used
methods for studies with interim monitoring plans, which control type I error rate, protect statistical
power, and avoid false positive/negative ﬁndings. However, when both eyes (clustered) from a patient
are included in a study, group sequential methods accounting for the inter-eye correlation to the best
of our knowledge, essentially do not exist for all design options (different ways of randomizing both
eyes or one eye of a patient) in the literature. In this application, through a collaborative effort between
George Washington University and Wills Eye Hospital, that combines theoretical and applied statistical
expertise, we propose to develop and evaluate a uniﬁed group sequential design for vision research
that accommodates all possible design options while accounting for inter-eye correlations when both
eyes of a patient are included in the study. These design options include: 1) only one eye eligible and
randomized per person; 2) paired eye design; 3) paired eye design plus cases contributing one eye
only; 4) both eyes on the same study arm (clustered) plus cases contributing one eye only; and 5) two
eyes either on the same or different arms plus cases contributing one eye only - uniﬁed design, which
includes the ﬁrst four designs as special cases. The proposed project aims to achieve the following
speciﬁc aims: 1) to propose, investigate and evaluate design properties for group sequential trials with
clustered (eye level) continuous endpoints; 2) to propose, investigate and evaluate design properties
for group sequential trials with clustered (eye level) binary endpoints; and 3) to propose, investigate
and evaluate design properties for group sequential trials with clustered (eye level) survival endpoints.
Completion of these proposed aims will provide investigators with a new suite of statistical tools to
improve the design and monitoring of long-term trials and minimize the likelihood of making interim
decisions that might lead to unnecessary study continuation or early stopping. Each speciﬁc aim will be
achieved through the following steps: 1) rigorously establish the theoretical properties of the proposed
methodology; 2) examine the ﬁnite-sample performance through extensive simulation studies; and
3) apply the proposed methods to interim data from real example eye trials (the Age-Related Eye
Disease Study, the HOme Monitoring of the Eye Study, the Cryotherapy for Retinopathy of Prematurity
Trial, and the Early Treatment for Retinopathy of Prematurity Study) to demonstrate the usefulness
of the proposed methods. Computer programs implementing the new methodology will be made
available through an R Shiny App with a web interface for practitioners' easy access and convenient
use. Detailed usage guides and documentation will be provided.

Public health relevance
PROJECT NARRATIVE In this application, we propose to develop a uniﬁed group sequential design to account for inter-eye correlations in interim analyses when both eyes for at least some patients are included in a randomized clinical trial. We will investigate the proposed group sequential design's theoretical properties through the use of inﬂuence functions for the most common types of endpoints such as continuous, binary, and survival data, by considering all possible options of randomizing eyes in a clinical trial. This new methodology will help investigators improve the design and monitoring of long-term trials and minimize the likelihood of making interim decisions that might lead to unnecessary study continuation or early stopping.